USC-Yale Roybal Center for Behavioral Interventions in Aging

Abstract
The Administrative Core plays a crucial role in promoting collaboration among researchers within the Center
and the National Institute on Aging. Its main objective is to advance scientific knowledge by conducting studies
on the mechanisms of behavior change related to interventions aimed at improving medical care delivery. As
part of its specific aims, the Administrative Core manages the External Advisory Committee, which determines
the priorities for the request for applications. Additionally, it organizes a review panel to assist in the selection
of clinical trials. This process involves grant scoring and providing recommendations to the Principal
Investigators. Furthermore, the Administrative Core collaborates with the Behavioral Intervention Development
Core to provide scientific, statistical computing, and project management resources to awardees. This support
enables them to carry out their work at different stages of the research process and explore behavior change
mechanisms applicable across various settings. During clinical trials, the Administrative Core works alongside
the Behavioral Intervention Development Core to monitor the trials, develop evaluation metrics, and code
mechanistic targets. This ensures that the highest-priority behavioral interventions are identified, selected, and
supported in research endeavors. Additionally, the Administrative Core coordinates travel arrangements,
disseminates trial results, and expands the network of implementation partners through the Center's External
Advisory Committee. The Center follows the NIH Stage Model for behavioral research, evaluating the
relevance of fundamental social and cognitive principles and applying them appropriately to each mechanism
within each stage of the research process. The Administrative Core collaborates with trialists to develop
training materials and establish project pathways within the NIH Stage Model on a yearly basis. Throughout the
award period, the Administrative Core's significant contribution lies in fostering close collaborations between
behavioral scientists and clinical researchers. This collaboration aims to address pressing population health
concerns that contribute to the overuse of low-value services and the underuse of more effective services in
the nation.

Public health relevance
PER RFA, NO NARRATIVE NEEDED FOR COMPONENT ON MULTI PROJECT SUBMISSION.